The Development of a Biatrial Catheter for a Cardiopulmonary Support System in Pulmonary Arterial Hypertension

ABSTRACT
Pulmonary arterial hypertension continues to be a devastating chronic disease. Despite a variety of new
therapies, this disease process remains highly morbid and fatal. Most therapies are only temporizing and are
minimally effective because of the insidious onset and late recognition of this disease process. Double lung
transplantation is the only effective treatment; however, because of scarcity of organs and listing inequities, most
patients are unlikely to receive a transplant while on the waiting list. Developing an effective long-term support
system that can offload the right ventricle and protect the pulmonary vasculature would provide a bridge of
support and potential for recovery or management on pharmacological support. The objective and long-term
goal of this project is to design a catheter that will eventually be coupled with a pulmonary support system that
can prolong the survival and enhance the ability to medically treat patients with pulmonary artery hypertension,
as well as provide a chance for those on the lung transplant waiting list to receive an organ. We intend to
accomplish this by developing an innovative dual lumen catheter that can be positioned and fixed for a prolonged
period of time using a novel engineering mechanism and will properly unload the right ventricle and pulmonary
vasculature via an inter-atrial configuration. This will further include an innovative monitoring system to monitor
and control flows and protect a deconditioned left ventricle, preventing left sided heart failure.

Public health relevance
PROJECT NARRATIVE The innovative design of this catheter when coupled with a compatible pulmonary support system would provide patients with severe pulmonary arterial hypertension and right ventricular failure a therapy that can significantly improve the survival and provide time for medical therapies to be initiated and take effect. This will also allow the patient to be supported while they are waiting on the transplant list. In the long-term and future progress, this cannula and eventual system design will allow for ambulation and portability so the patient would not need to reside on bedrest in a hospital while waiting for a donor organ and provide a better chance to rehabilitate.